Outreach, Recruitment and Engagement Core

Outreach, Recruitment and Engagement Core : Project Summary
Alzheimer’s Disease and Related Dementias (ADRD)’s incidence, prevalence, risk factors, and clinical features
vary by race and ethnicity. However, across ADRD studies, recruitment of diverse research participants remains
a formidable challenge. For example, few participants with dementias are from underrepresented groups (URGs)
including 8% Latinx, 2% Asian, and <1% from Indigenous and Pacific Islander communities. These shortfalls are
likely due to a confluence of barriers, including mistrust of academic research programs, inadequate outreach
programs without consideration for culture and language, lack of trained bilingual and bicultural community
educators in the research team, and limited knowledge about ADRD research opportunities by URG
communities. At the same time, this underrepresentation presents a significant opportunity to build strong
bidirectional partnerships with URG communities, caregivers and clinical and community-based organizations
serving these communities. In the 2019-2025 cycle, the University of Washington Outreach, Recruitment and
Engagement (ORE) Core applied strategies grounded on community-based participatory research (CBPR)
approach and established a dynamic community advisory board representing Latinx, Blacks, and Asian
American and Pacific Islander communities, developed a culturally and linguistically centered outreach and
retention programming, and equipped the team on best practices for community engagement. Working in tandem
with the UW ADRC Native Research and Resource Core, these strategies increased representation of URGs in
the Clinical Core from <10% in 2020, to currently ≈25% (2024). In the new cycle, ORE Core will focus on growing
the community-ADRC partnerships grounded on CBPR, health equity, and intersectionality, to further expand
the diversity of the Clinical Core cohort geographically, demographically and clinically, and address the concerns
and needs of URG communities for brain donation. We specifically aim to 1) Grow and sustain a durable and
equitable community-ADRC collaboration to ensure bidirectional communication of ADRD research and
education to patients, caregivers, clinicians, community-based organizations, and public health departments
across urban and rural regions; 2) With community partners, promote recruitment and retention of
geographically, demographically, and clinically diverse participants into the clinical core using community
informed best practices and establishing a referral network of local providers, neighborhood clinics, and
community-based organizations; and 3) With community partners, improve readiness of URG communities to
ADRD research by addressing barriers to and promoting facilitators of research participation with an emphasis
on brain donation. Our proposal builds upon our existing successful community-ADRC partnerships focusing on
the model of knowledge exchange through bidirectional learning, co-design of outreach and engagement
programs and collective reflection while conducting rigorous science aligned with communities’ priorities.